The microenvironment in bone marrow hematopoiesis

Abstract:
Blood cell production takes place via stepwise differentiation from hematopoietic stem cells into multipotent
progenitors that give rise to unipotent progenitors responsible for producing each of the major blood cell
lineages (lymphocytes, monocytes, neutrophils, and red blood cells). This process takes place inside the
marrow of the bone where a unique microenvironment provides supportive and regulatory signals that regulate
stepwise blood cell differentiation. We and others have shown that the bone marrow microenvironment is
spatially and functionally heterogeneous and contains local structures with diverse and unique functions in
homeostatic, inflammatory, and regenerative hematopoiesis. Our ability to manipulate hematopoiesis to treat
disease has been hampered by our lack of understanding of these anatomical cues.
Our long-term research objective is to define the physiology of blood cell production in the bone marrow tissue
in homeostasis and stress. My short- and medium-term research program (the focus of this proposal) will test
the hypothesis that the bone marrow has a high degree of spatial organization; it contains discrete specialized
vascular microenvironments -discovered by us using new imaging approaches- that recruit and regulate
myeloid and erythroid progenitors and dictate how the bone marrow functions in homeostasis, inflammation, or
regeneration. We will carry out the following complementary 3-part research program in the following areas: (1)
Dissect the function of specialized microenvironments that function as niches for each major blood lineage
during homeostasis, with a focus on understanding how hematopoietic cells move through different specialized
microenvironments as they differentiate. (2) Determine how specialized sinusoids function as “antennas” to
sense inflammation and decide which -and how- hematopoietic progenitors respond to inflammation. (3)
Discover how hematopoietic stem cells and progenitors engraft in the bone marrow after transplantation and
define how two types of specialized microenvironments regulate short-term and long-term hematopoietic
recovery after transplantation. Together these studies will provide a new framework for understanding blood
differentiation, dissecting hematopoiesis during disease, and designing systems for multilineage blood cell
production ex vivo

Public health relevance
Narrative: Using state of the art imaging and mouse genetics we will identify the cellular composition and molecular mechanisms through which specific vascular microenvironments in the bone marrow regulate hematopoiesis in a lineage-, bone-, and insult-specific manner. We will establish new paradigms to understand the normal physiology of hematopoiesis, the pathophysiology of blood diseases, and to build new organ systems capable of producing blood ex vivo.